Translation Core

TRANSLATION CORE: PROJECT SUMMARY/ABSTRACT
The Translation Core (TC) supports the mission of Southern California Center for Children’s Environmental
Health Translational Research (SC-CCEHTR) to leverage the existing scientific knowledge base to build diverse
interdisciplinary teams and foster multidirectional stakeholder engagement. In addition to traditional children’s
environmental health scientists, the TC brings together experts in communication, policy, dramatic arts, urban
planning, land-use design, implementation science and program evaluation around the Center’s theme of
Urbanism, Air Pollution, Children’s Health and Environmental Justice. The Translation Core will draw on
the Center’s extensive scientific base from which to build diverse interdisciplinary teams and community
partnerships around three Focus Areas: 1) Youth Engagement & Community Science; 2) Urban Design & Policy
Solutions and 3) Communication & Public Knowledge. These are needed to translate research effectively and
reduce the burden of air pollution-related disease, disability and environmental health disparities in children. The
overarching goals of the TC are to increase environmental health literacy among the public and policymakers to
inform action to protect children’s environmental health; collaboratively develop and disseminate key research
findings to local and national audiences through innovative journalism; build knowledge and capacity of urban
environmental justice communities to leverage scientific studies and resources; and provide tools and strategies
to eliminate, reduce or mitigate adverse environmental exposures. A robust evaluation mechanism leveraging
multidisciplinary expertise in communication, network analysis, and implementation science will assess efficacy
and provide a strong basis for scholarship. The TC will build upon two decades of experience at the intersection
of air pollution, children’s health and translation that has resulted in successful models to engage communities
and decision-makers to address environmental health disparities related to traffic and goods movement in
Southern California. Investigators have collaboratively created models to democratize the use of scientific
information as a tool for action at the community and policy level. The TC will use this experience to develop and
integrate novel methods to train residents, youth, and policymakers in air pollution science, collaborate with
multiple stakeholders implementing an effort to assess and reduce toxic air emissions at a neighborhood scale,
and expand our engagement program to include storytelling, participatory urban planning and theatre. In
addition, we will leverage traditional and nontraditional communications techniques such as social media,
geographically targeted email, newsletters and infographics to update stakeholders on current science and
engage the power of communities to reduce environmental health burdens through policy change.